Tailored Approaches to Reduce Distress and Improve Self-Management for Veterans with Diabetes (TARDIS)

Background: Diabetes self-management is critical to sustaining optimal health following diagnosis.
Diabetes distress (DD) is a crucial factor that influences a Veteran’s engagement in diabetes self-
management. DD is distinct from depression, and includes four domains (i.e., regimen, emotional,
interpersonal, healthcare provider). The presence of DD negatively impacts engagement in self-management
and HbA1c. Despite interventions aimed at decreasing DD, these interventions have shown minimal lasting
effects. One reason may be because interventions do not tailor information to an individual’s DD.
Significance/Impact: This proposal will be the first to examine the impact of correlating factors on DD,
and then design and test a self-management intervention tailored upon a Veteran’s DD type. This proposal
addresses the [VHA Strategic Plan Priority areas of utilizing resources more efficiently and improving the
timeliness of services, and the HSR&D Research Priorities of Population Health/Whole Health and Primary
Care Practice. This proposal’s findings can improve both care delivery and health outcomes of Veterans, as we
will help facilitate the Veteran’s linkage to ubiquitous, existing VHA and community services].
Innovation: This proposal will develop an intervention that targets sub-optimal T2D self-management by
providing tailored self-management information in conjunction with connections to supportive services. We will
identify how, and to what extent, DD and its factors, influence a Veteran’s self-management behaviors.
Specific Aims: Aim 1 will examine the association of [psychosocial factors (depression, PTSD),
environmental factors (finances, support), self-management behaviors, and HbA1c with DD. These Aim 1 data
will inform the identification of modifiable factors and selection of the population] for a diabetes self-
management intervention for Veterans with T2D. Aim 2 will describe self-management challenges and
preferred learning strategies [to inform the intervention components and delivery approach for Veterans with
T2D. Obtaining in-depth perceptions of DD type, self-management strategies and challenges, and learning
preferences is essential to tailoring intervention components]. The purpose of Aim 3 is to design & pilot test an
innovative, tailored T2D self-management information and supportive services intervention for Veterans with
T2D, to promote engagement in self-management behaviors. In Aim 3 we will determine the feasibility and
acceptability of the intervention for Veterans with T2D.
Methodology: This proposal uses an explanatory, sequential mixed-methods design to describe DD in a
sample of Veterans who receive care at Durham. In Aim 1 we will survey Veterans (n = 200), and balance
enrollment by HbA1C (< 9 or ≥ 9) and medication use (insulin, no insulin). In Aim 2 we will conduct semi-
structured interviews with a sub-sample (n = ~36) of Veterans surveyed in Aim 1. We will balance enrollment
by HbA1C, medication use, and DD level as operationalized by the Diabetes Distress Scale (low, moderate,
high). In Aim 3 we will develop and refine the intervention using findings from Aims 1 & 2 and strategies
successfully used by co-mentors. To develop the intervention we will conduct semi-structured interviews with
stakeholders (n = ~20: physicians, nurses, administrators) to review components (e.g., learning approaches,
relevant VA/community resources) to ensure relevancy. We will modify components and the delivery strategy
as needed. Then, we will test the intervention with 30 Veterans to evaluate [feasibility and acceptability], and
utilization of recommended supportive services, using quantitative and qualitative approaches.
Implementation/Next Steps: The next steps include dissemination of findings about DD, and its
correlates, and the development of an IIR. This IIR will be a Phase III efficacy trial and will be sufficiently
powered to test the effects of providing self-management information and connections to supportive services
tailored to a Veteran’s DD to improve HbA1c.

Public health relevance
Veterans with diabetes may become overwhelmed with the self-management behaviors needed to maintain optimal health. Veterans may experience diabetes distress (DD), a concept distinct from depression, due the amount and frequency of these behaviors. DD negatively influences the Veteran’s engagement in self- management and subsequent HbA1c levels. Previous interventions do not tailor T2D self-management information to a Veteran’s DD, which may be one reason interventions are ineffective at reducing DD. This proposal examines the impact of correlating factors (e.g., sociodemographic, psychosocial, and environmental) on DD using surveys and semi-structured interviews. Then, these findings will be used to design and test an intervention that provides T2D self-management information in conjunction with facilitating a connection to supportive services tailored to a Veteran’s DD. This proposal will prepare Allison Lewinski, PhD, MPH, RN for a career as a scientist at VHA focused on developing methods to improve health outcomes among Veterans.